Effects of Covid-19 Pandemic on Long-Term Care for High Need Older Adults with and without Alzheimer's Disease and Related Dementia.

PROJECT SUMMARY
Nearly 20 million adults (38%) aged 65 and older have limitations with one or more self-care activities (e.g.,
dressing, getting out of bed) and one in ten older adults are living with Alzheimer’s Disease and Related
Dementias (ADRD). Together these two overlapping groups of “high-need” older adults typically rely on a
variety of long-term care (LTC) sources to assist with daily activities, including family and unpaid care, paid
care in the home, residential care such as assisted living and nursing home care. Inadequate care may lead to
adverse consequences in daily self-care and avoidable health care utilization. The sudden onset of the COVID-
19 pandemic may have profoundly affected access to and use of LTC and contributed to further adverse
consequences for high-need older adults, particularly for those living with ADRD. This project will draw upon
two complementary longitudinal, nationally representative surveys of older adults–the Health and Retirement
Study (HRS) and the National Health and Aging Trends Study (NHATS)–linked to geographic data and
Medicare claims. Using statistical approaches that strengthen our ability to draw causal inferences, we will: 1)
Evaluate the short-term impact (2018-2020) of the COVID-19 pandemic on the type and amount of LTC use,
comparing high-need older adults with and without ADRD and identify arrangements more likely to be “stable”
with lower risks of change. 2) Determine whether care trajectories were disrupted after the start of the
pandemic, comparing high-need older adults with and without ADRD from 2016 through 2024/2025. 3) Assess
the impact of COVID-19 on adverse consequences related to care gaps among high-need older adults with
and without ADRD. We will estimate the effect of the COVID-19 pandemic on self-reports of unmet need (using
NHATS) and claims-based measures of avoidable hospitalizations and emergency department visits (using
HRS) for those with and without ADRD. Detailed geographic data will allow us to take into account local
conditions while identifying more “vulnerable” care arrangements with higher risks of adverse consequences.
The results of this project will provide a comprehensive understanding of the COVID-19 pandemic’s impact on
LTC outcomes in the short and longer term. This study aligns with NIA’s priority to understand community
support for dementia care, in particular the determinants of availability LTC, LTC utilization and how the effects
of community level factors including infrastructure and risk environment.

Public health relevance
PROJECT NARRATIVE This project will uncover short and longer-term effects of the COVID-19 pandemic on the use of long-term care (LTC) and adverse consequences related to gaps in care. By focusing on high-need older adults in the U.S. and comparing effects for those living with and without Alzheimer’s Disease and Related Dementias (ADRD), the project will provide guidance to public health officials on how to improve the stability and resiliency of LTC arrangements to meet older adult’s care needs in the context of an aging population.